A mixed-methods investigation of parental burden and adolescent service use following discharge from psychiatric hospitalization

Project Summary/Abstract
Adolescents (age 12-17) are disproportionally impacted by mental health challenges. Suicide is a leading cause
of death among this age group, with rates of psychiatric inpatient service use consistently increasing since the
mid-2000s. Youth psychiatric hospitalization can be traumatic for families and the period following hospitalization
is associated with increased risk of repeat suicide attempts and rehospitalization. Increased risk during this time
may be due, in part, to low rates of follow-up service use. One factor that plays a substantial role in youth service
use is parental burden (i.e., difficulties perceived to be caused or exacerbated by a child's psychiatric symptoms).
However, research has not yet explored how parental burden is related to follow-up service use in the post-
hospitalization period, or how disparities may influence this relation. Familial socioeconomic status (SES) may
be particularly important to consider in this context. There exists a myriad of barriers faced by families of lower
SES that impact access to and quality of mental health care. The present study seeks to address these gaps
using a mixed methods design. The first aim of this study is to investigate the bidirectional associations between
parental burden and youth service use over time following discharge from psychiatric hospitalization. The second
aim is to examine how SES impacts the longitudinal relations between parental burden and youth service use.
The third aim is to compare the lived experiences of 252 mothers with a recently psychiatrically hospitalized
adolescent from high and low SES backgrounds, with a focus on perceptions of burden. Broadly, the fellow’s
training goals associated with the proposed study and long-term career plans are to: develop comprehensive
knowledge of relevant literatures, such as processes of post-traumatic growth and stress in families, health
disparities, and culturally responsive care with underserved youth and families; develop proficiency in qualitative,
mixed-methods, and advanced quantitative statistical design and analysis; and improve research dissemination
skills. This will be accomplished through coursework, attendance at targeted workshops, hands-on research and
clinical experience, directed readings, and regular mentorship meetings. With the support of a dedicated and
experienced mentorship team, this research study and training plan will set the stage for the fellow’s long term
research goal, which is to conduct culturally responsive, trauma-informed, and family-based treatment research.

Public health relevance
Project Narrative This project will help us to understand bidirectional relations between parental experiences of burden (i.e., difficulties perceived to be caused or exacerbated by a child's psychiatric symptoms) and their adolescents’ mental health service use following psychiatric hospitalization, with attention to the effect of socioeconomic status on this association. This study will employ a mixed methods design with a sample of 252 mothers of recently hospitalized adolescents. Findings may be used to improve the cultural responsiveness of care coordination and intervention post-hospitalization which may reduce health disparities, youth suicide risk, and the substantial burden associated with youth psychiatric hospitalization.